Integrating biomaterials and genomic tools for glycan-based programming of immune cells

Project Summary/Abstract.
Dendritic cells are key decision makers of the immune system and are equipped with receptors that enable them
to execute molecular programs in response to foreign signals. Glycans, which bind lectin receptors on the surface
of dendritic cells, can influence dendritic cell signaling to adaptive immune cells. Programmable technologies
integrating glycans to direct immune cell phenotypes would be broadly useful from both a fundamental biology
and a biological engineering perspective. Biomaterials such as hydrogels can present programmable molecular
cues and are an ideal platform with which to study the impacts of glycans on immunity and to translate insights
into clinical solutions. We will advance self-assembling modular hydrogels that programmably display glycan
ligands (Aim 1). These glycomaterials will be screened for their ability to initiate maturation of innate immune
cells and direct immune cell phenotypes. We will use immunophenotyping and transcriptomic readouts to screen
glycomaterials for their ability to dictate immune cell phenotypes and fate decisions. In parallel, we will implement
functional genomic screens in dendritic cells, generating a library of cells with impaired abilities to sense and
respond to glycan ligands. We will evaluate cytokine secretion in edited cells following glycomaterial stimulation
and compare to responses in wildtype cells. Thus, we will identify key regulators of glycomaterial recognition and
subsequent signaling. Finally, we will use glycomaterial hydrogels as a platform for immunotherapy (Aim 3).
Glycomaterials will be used to support co-culture of antigen-pulsed dendritic cells and autologous antigen-
reactive T cells. We will evaluate the ability of glycan-educated immune cells to provide protection in murine
models of melanoma. We anticipate that our approaches will reveal new mechanistic insights into glycobiology
and how it shapes immunity. The proposed research will be carried out in the Department of Biomedical
Engineering at Columbia University, under the sponsorship of Dr. Santiago Correa and Dr. Kam Leong. The
expertise and facilities in this training environment will strongly enable the proposed research.

Public health relevance
Project Narrative Glycans are important modulators of immunity and are key signals detected by antigen-presenting cells, such as dendritic cells. This proposal seeks to develop glyco-engineered polymer and protein-based biomaterials as tools to direct immune cell phenotypes. This work will enable the design of glycan-directed immunotherapies for the treatment of cancer and infectious diseases.